Regulation of hematopoietic stem cell function by prenatal folate status

Prenatal folate status predicts risk for a range of adult diseases, including cardiovascular
disease, obesity, and colon cancer, but the driving pathogenic mechanisms are unknown. The
proposed work will test the hypothesis that maternal folate status programs risk for
inflammation-related disease across the lifespan in offspring by altering hematopoietic stem cell
(HSC) function from development onwards. Folate-mediated one carbon metabolism provides
the sole source of one-carbons for nucleotide biosynthesis and cellular methylation reactions.
Impaired folate status due to altered dietary intake or common genetic polymorphisms affects
proliferation, genomic stability, and, most notably, epigenetic regulation. Given that adult HSC
function is altered by changes in epigenetic regulation, metabolism, and DNA damage, we
hypothesize that early perturbations in folate status will influence HSC development and
function by influencing these parameters during fetal development. We have recently shown
that prenatal immune perturbation can shape long-term hematopoiesis and immune function by
influencing both the composition and output of HSCs postnatally. Here, we will maintain mice on
folic acid (FA) deficient or FA-supplemented diet throughout gestation, and test the effects of
manipulating folate status on hematopoietic development and adult HSC function. In Aim 1, we
will determine the immediate impact of maternal folate status on fetal folate metabolism, fetal
hematopoiesis, and fetal HSC function by transplantation. In Aim 2, we will test how modified
folate status in the prenatal period influences hematopoiesis and HSC function into adulthood.
Our data will provide novel information on how early life conditions program HSC function and
output across the lifespan.

Public health relevance
The Developmental Origins of Health and Disease (DOHaD) hypothesis purports that environmental conditions in early life influence long-term health outcomes and disease risk, but the underlying mechanisms are unknown. We hypothesize that prenatal folate status affects adult health and disease by impairing epigenetic regulation of gene expression in developing hematopoietic stem cell (HSCs). Our proposed work will directly test how prenatal folate status influences HSC development and function across the lifespan.